Biospecimens

Core 1 Abstract
Given the poor prognosis for patients with chronic lymphocytic leukemia (CLL) who develop Richter
syndrome (RS), an expanded molecular understanding of RS is critical both to understand which
patients are at greatest risk and to develop improved therapeutic strategies. There is currently no
effective standard of care therapy for RS patients, and this is likely to be a growing problem, as
increasing numbers of CLL patients treated with novel agents are living longer, putting them at risk of
developing RS. The fundamental mission of Core 1 is to ensure a robust tissue resource of clinically-
annotated primary samples from patients with RS treated both on and off clinical trials. Additionally, we
will maximize opportunities to procure matched CLL samples—highly feasible because of our long-
established deep CLL sample repository-- so that clonal relationships between RS and antecedent CLL,
and molecular and functional differences between these two related entities, can be studied. We will
also continue our systematic banking of cell and plasma samples from all CLL patients seen at our
center. We will emphasize banking those at high risk for developing RS, both prior to any evidence of
transformation and at the time their CLL has progressed to RS, for evaluation of cell-free DNA as a
method of early detection. In this fashion, the resources of this Core will supply the Projects with the
necessary primary RS and CLL tissue to understand the genesis, biology, and most promising
therapeutic targets in RS. We have established the infrastructure and a coordinated workflow to obtain
fresh RS biopsies both from patients enrolled on treatment trials and those treated outside the trial
setting. We have well-established systems to efficiently distribute cellular and nucleic acid material
across the Program, for deep molecular profiling as described in the Projects. We have further
coordinated with external clinical trial sites to share processing SOPs so that biopsy material can be
obtained and processed in a uniform fashion across studies and institutions. We already have sufficient
RS patient samples in our BioBanks to allow us to immediately begin to generate data through the
Projects. Through the efforts detailed in this Core section, we plan to significantly increase the
availability of such samples to fuel the science of the Projects throughout the timeline of this award and
beyond. These efforts will provide a firm foundation for future translation of the research findings into
potential novel biomarkers of RS development, as well as the biology of RS itself and its potential
therapeutic vulnerabilities, thereby facilitating the development of novel clinical trials.

Public health relevance
Narrative Core 1 will generate a large repository of molecularly and clinically-annotated primary samples from patients with Richter's syndrome and patients with chronic lymphocytic leukemia at high risk of developing Richter's syndrome. These primary samples will be obtained from patients on and off clinical trials at our center and will include extensive collection of cell-free DNA designed for early detection of RS. Samples from this Core will be efficiently distributed to the Projects to provide the primary patient material essential to elucidating the pathogenesis and therapeutic vulnerabilities of Richter's syndrome.